Chronic Stress, Glucocorticoids, and Progesterone in Brain Aging

Evidence indicates that prolonged/ repeated behavioral stress promotes brain aging. This is thought to be due,
at least in part, to stress associated glucocorticoid (GC) secretion, which in turn binds to glucocorticoid receptors,
exerting transcriptional and other effects. A key downstream mediator in this signaling pathway, serum-and-
glucocorticoid kinase 1 (Sgk1) accelerates, and the female sex steroid progesterone (P4) blunts, the effects of
GCs. However, despite the negative clinical consequences of chronic stress exposure with aging and/or in
female subjects, little work has examined how aging may change the stress response, the mechanisms through
which stress may accelerate brain aging, the degree to which stress-accelerated aging is dependent on GC, is
driven by Sgk1, or is inhibited by P4. Our preliminary data suggests that hippocampal Sgk1 is upregulated by
aging, stress, and GCs in white matter oligodendrocytes, and that the female sex hormone progesterone (P4)
blunts the effects of stress/GCs and may serve as an endogenous protectant that is lost with age in females.
To address these knowledge gaps, we propose 3 aims to investigate: the age-course of the response to chronic
stress or chronic GCs in males and females; whether viral overexpression of Sgk1 exacerbates, or systemic P4
administration ameliorates, stress-accelerated aging; and whether the pharmacologic sensitivity of hippocampal
tissue to GC and P4 is shifted with age or chronic stress/GC. Cognitive and anxiety-related behavior, blood
hormone measures, and a novel panel of 205 hippocampal genes that are robustly changed with aging across
multiple studies, will be used to test for stress/GC-accelerated aging and intervention effects, as will downstream
gray and white matter Sgk1 expression and microglial response to microinjury- two processes demonstrated to
be glucocorticoid sensitive and exaggerated in white vs. gray matter in preliminary data. Thus, the proposed
studies will yield essentially the first comprehensive test of the hypothesis that chronic stress accelerates
transcriptional brain aging and will illuminate sex differences in stress responsiveness and the potential roles of
GC, P4, and Sgk1 in gray and white matter. Even if all of our working hypotheses are rejected by the results, the
proposed studies should have translational value for geriatric medicine.

Public health relevance
The proposed studies in rodent models will yield essentially the first comprehensive test of the hypothesis that chronic stress accelerates transcriptional markers of brain aging. The studies will illuminate sex differences in stress and stress hormone responsiveness and the potential protective and mediating roles, respectively, of progesterone and SGK1 (a key effector in glucocorticoid system signaling) in gray and white matter. Even if our working hypotheses are rejected, the proposed studies should have translational value for geriatric medicine.